A PHASE I STUDY OF THE GARFT INHIBITOR AG2034 IN PATIENTS WITH ADVANCED CANCER

To study the pharmacokinetics and pharmacodynamics of AG2034.To evaluate the safety and dose tolerance and determine induced antitumor effects when given intravenoulsy to patients with advanced cancer.